Mitosis in Confining Microenvironments

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cell division is a fundamental process of broad importance, yet the mechanisms underlying how cells grow and elongate in highly confining microenvironments for cell division are unclear. Therefore, the proposed research on understanding of the force-based mechanisms of cell division in highly confining microenvironments, via combined experimental and computational approaches, is relevant to part of NIH’s mission that seeks to develop fundamental knowledge that will help reduce the burdens of human disability and disease. Ultimately, it is anticipated that this study will uncover new insights and provide a new perspective on cell division, which will contribute to our understanding of processes in development, homeostasis, regeneration, and disease, and will also potentially lead to new therapies.